Novel CCR2 PET for Pancreatic Cancer Imaging and Prediction of Response to Standard and CCR2-Targeted Therapy

PROJECT SUMMARY/ABSTRACT
Development of effective therapies is an urgent, unmet medical need for patients with pancreatic ductal
adenocarcinoma (PDAC). The advent of immune checkpoint antagonists such as anti-PD-1 and anti-CTLA4
antibodies has revolutionized treatment of some cancers but remains unsuccessful in PDAC. We and others
showed that the tumor microenvironment (TME) of PDAC is rife with myeloid-derived suppressor cells
including inflammatory monocytes (IMs) and tumor-associated macrophages (TAMs) that stifle the effect of
chemotherapy and anti-tumor immunity. Excessive production of CCL2 in PDAC has shown to result in tumor
growth, dissemination, local immunosuppression, and resistance to chemotherapy. Targeting a key chemotactic
mechanism, the C-C motif chemokine ligand 2 (CCL2)/ C-C chemokine receptor type 2 (CCR2) axis, that draws
these cells to the TME potentiates the efficacy of chemotherapy in preclinical mouse model and a clinical trial
conducted at our institution, setting the premise to further confirm and optimize CCR2-targeted strategies in
PDAC. We are in the process of opening a phase I/II clinical trial combining a CCR2/5 inhibitor, chemotherapy
and anti-PD-1 agent. Realizing that not all patients will benefit from this regimen, a diagnostic tool capable of
assessing CCR2 abundance while predicting and monitoring treatment response will be invaluable. CCR2
inhibitor slows tumor progression, prevents metastasis in mouse models of PDAC, and potentiates effect in
patients with border-line resectable or locally-advanced PDAC (NCT01413022). We have developed a CCR2-
PET tracer (64Cu-DOTA-ECL1i) and shown its sensitivity and specificity in imaging CCR2 in multiple preclinical
inflammatory disease models and PDAC models and PDAC human specimens. Our PDAC PET imaging in
genetic mouse model demonstrated early, sensitive, and specific detection of CCR2 in tumors. The first-
in-man imaging showed low accumulation of 64Cu-DOTA-ECL1i in normal pancreas and liver (a common
site of metastatic disease where CCR2-bearing IMs and TAMs infiltrate the pre-metastatic sites prior to
establishment of metastatic clones) with rapid blood and renal clearance, indicating the potential of this PET
tracer for CCR2 detection in PDAC patients. We hypothesize that 64Cu-DOTA-ECL1i can sensitively and
specifically detect CCR2 in PDAC, track the variation following CCR2-targeted treatment, and likely prescreen
PDAC patients for CCR2-targeted therapy. We propose to evaluate whether tumor uptake of 64Cu-DOTA-ECL1i
correlates with tumor expression of CCR2 and response to standard chemotherapy in PDAC patients. We also
will evaluate whether tumor uptake of 64Cu-DOTA-ECL1i predicts response to CCR2-directed therapy in PDAC
patients treated with CCR2/5 inhibitor and chemo-immunotherapy. The successful completion of this grant will
facilitate innovative means for clinical data interpretation, patient stratification, and therapy guidance.

Public health relevance
PROJECT NARRATIVE This project seeks to fulfil an unmet need for CCR2-specific imaging test. Currently there is no clinical biomarker that can be used to select patients for CCR2-targeted therapy and to monitor response to such therapy. Considering the toxicity and the rate of response to CCR2-targeted therapy, it is crucial to be able to identify patients who may not response to this therapy in order to avoid the morbidity and expense associated with ineffective therapy.